Core B: Pharmaceutical Production

PROJECT SUMMARY / ABSTRACT – CORE B
Core B, Pharmaceutical Production, is responsible for the production of the monoclonal antibodies (MAbs),
the antibody conjugates, the alpha-emitting radionuclide astatine-211 (211At) and the 211At-labeled antibody
conjugates. The Core will produce anti-CD45 and anti-CD38 MAbs used in preclinical studies (Projects 1, 2
and 3) and produce clinical grade anti-human CD45 BC8 MAb and anti-human CD38 OKT10 MAb used in
clinical trials (Projects 2 and 3). The MAbs will be conjugated with a novel reagent (B10-NCS) to produce
MAb-B10 conjugates for radiolabeling with astatine-211 (211At). All MAbs and clinical grade reagents will be
produced, purified and vialed in the Biologics Production Facility (BPF) of the Fred Hutch. The B10-NCS
reagent and MAb-B10 conjugates used for preclinical studies will be produced in appropriate chemical
laboratories at the University of Washington. Clinical grade BC8-B10 conjugate and OKT10-B10 will be
produced, purified and vialed under current good manufacturing practice (cGMP) conditions in the Fred Hutch
BPF. Production, isolation and purification of the 211At will be done in the UW Medical Cyclotron Facility and
UW Radionuclide Production Laboratory. The 211At-MAb-B10 for preclinical studies will be conducted in UW
radiochemistry laboratory, and 211At-BC8-B10 and 211At-OKT10-B10 used in the clinical trials will be produced
in a cGMP facility at UW. Testing of the materials produced will be conducted at UW or Fred Hutch, depending
on the assay. Patient samples obtained from Projects 2 and 3 will be collected, processed and stored at the
Fred Hutch for use in Project 1.

Public health relevance
PROJECT NARRATIVE - Core B The radiolabeled antibodies produced under federally approved methods in Core B are critical for use in key clinical trials in patients, which will ultimately lead to development of minimally toxic hematopoietic cell transplant regimens for the treatment of patients with blood-based cancers. Production of these antibodies is made possible through the use of unique facilities at the Fred Hutch and the University of Washington.